The diverse roles of ER-Golgi trafficking machinery in autophagy and ER quality control

Project Summary
Selective autophagy pathways use cargo receptors to degrade organelles, organelle subdomains, and
misfolded proteins that fail to be degraded by the proteosome. Endoplasmic reticulum (ER) autophagy (also
called ER-phagy) is a selective autophagy pathway that acts in ER quality control. ER-phagy cargo receptors
connect an ER domain to the autophagosome biogenesis machinery via their ability to bind Atg8 family
members (LC3 or GABARAP in mammals). The studies in this proposal are aimed at addressing two important
unanswered questions in the field. First, we will ask how the conserved yeast ER-phagy cargo receptor, Atg40,
fragments domains of the ER that it targets for degradation. Second, we will ask how Atg40 loads ER domains
into autophagosomes, sealed double-membrane structures that are delivered to vacuoles (yeast) or lysosomes
(mammals) for degradation.
We have found that a non-canonical form of the yeast COPII coat subcomplex, Sec23-Lst1, works with
Atg40 to package ER domains into autophagosomes during ER-phagy. The COPII coat is a multi-subunit coat
complex that is known for its role in sorting ER proteins into transport carriers that traffic on the secretory
pathway. We identified a novel role for Sec23-Lst1 in ER-phagy that is independent of its role in secretion.
While the reticulon homology domain of Atg40 has been implicated in ER fission, it is unclear if Atg40 requires
Sec23-Lst1 to fragment ER domains. An in vitro approach is needed to unambiguously answer this question.
We have found that a variation of the COPII coat in vitro vesicle budding assay can be used to assess the
requirements for Atg40-mediated ER fission. The COPII coat is formed by the sequential interactions of the
Sar1 GTPase and cytoplasmic coat subcomplexes. We will use this in vitro assay to address if Atg40, Sec23-
Lst1 and Atg8 are all needed for fission. Additionally, we will determine if purified Sar1, and other purified
cytoplasmic COPII subcomplexes are also required. A long-term goal of these studies is to develop a similar in
vitro ER fragmentation assay with mammalian COPII coat subcomplexes.
To address how Atg40 sequesters membrane domains into autophagosomes, we will take advantage
of an unusual phenotype we observed in lipid droplet (LD) deficient cells. Lipid droplets are ER-derived
organelles that contain a neutral lipid core, triacylglycerides (TAG) and sterol esters (SE), surrounded by a
phospholipid monolayer. When yeast cells are devoid of LD, resident ER membrane proteins fail to be
delivered to the vacuole via ER-phagy. This defect appears to be due to the inability of the cargo receptor,
Atg40, to sequester ER domains into autophagosomes. We will perform biochemical, genetic and localization
studies to ask how LD are needed to couple Atg40 to its cargo. A long-term goal of these studies will be to
address the role of LD in mammalian ER-phagy. These studies will be relevant to variety of metabolic
disorders in humans, including diabetes and obesity.

Public health relevance
Project Narrative Selective autophagy pathways use receptors to fragment and load membrane domains into autophagosomes that are targeted for degradation. Our studies are focused on understanding how endoplasmic reticulum (ER)- Golgi trafficking machinery and lipid droplets mediate these events during ER autophagy. This work is likely to advance our understanding of quality control in the ER and will have significant medical implications for the study of diabetes and other metabolic disorders.